Biological validation of phage host-range identified by proximity guided metagenomics

Abstract
Phages are viruses that infect bacteria and have the potential to be used as a clinical tool for treating infectious
diseases and gut microbiome-related disorders. Understanding phage-host interactions can improve the ability
to use phages as a treatment option, and potentially lead to the development of new therapies. However,
current methods for studying these interactions are low-throughput and culture-based, limiting progress in
phage therapy research. Proximity ligation sequencing, which uses in vivo crosslinking between phage and
host genomes, is a high-throughput sequencing tool which can be used to read out these associations.
However, no rigorous experimental validation has yet been performed to verify these interactions, nor to
characterize the analytical performance of this approach.
The objective of this project is to establish proximity ligation sequencing as a reliable scientific tool for studying
phage-host associations. We propose to use a combination of gold-standard microbiological methods and
advanced sequencing tools to rigorously validate and define the performance of proximity ligation sequencing
for studying phage-host interactions. We will determine the sensitivity and specificity of proximity ligation
sequencing using both defined microbial communities and natural fecal microbiome communities. In addition,
we will estimate the positive predictive value of proximity ligation-identified phage-host associations in complex
microbial communities using phage isolation techniques. These experiments will provide key statistical
parameters of reliability, unlocking a high-throughput, culture-independent method of characterizing phage-host
interactions. This approach would enable new avenues in phage-based applications, including the
development of phage-based therapies for infectious disease, gut dysbiosis, and the targeted manipulation of
microbiomes.

Public health relevance
Narrative Phages are viruses that infect bacteria with high specificity, and have the potential to be used clinically to target bacteria which cause a variety of human diseases. We propose the rigorous experimental validation of a tool that can help identify these phages, and importantly which specific bacteria they infect. By identifying phages that interact with pathogenic bacteria, we can speed the development of phage-based treatment options and develop new therapies to treat microbial diseases.